Metabolic Vulnerability of Synapses in Neurodegenerative Disease

Abstract
Age-related neurodegenerative diseases place a substantial and increasing socioeconomic burden on society.
Age-related dementias including Alzheimer’s disease represent some of the greatest unmet medical
challenges facing the aging population in the US. To date clinical interventions for these diseases have had
very modest impact despite major efforts to develop new therapeutics. This landscape suggests that we are
still missing fundamental information regarding the root cause of these diseases and the specific cellular
vulnerabilities that lead to disease progression. We propose that a critical element of theses disease may
relate to local synaptic metabolism. The brain is highly vulnerable from a metabolic point of view: severe
hypoglycemia results in overt and severe neurological problems including delirium and coma. Furthermore, as
we age (and aging is the strongest correlate of all these afflictions) the efficiency with which we can deliver fuel
to tissues (including the brain) and convert this fuel into the useful biochemical currency, the high-energy
intermediate adenosine tri-phosphate (ATP), both degrade. Although these neurodegenerative disorders
ultimately lead to neuronal death it is thought that much earlier symptomatic problems arise from synaptic
dysfunction. My laboratory recently discovered that nerve terminals represent one of the likely loci of the
brain’s metabolic vulnerability: they consume large amounts of ATP but store little rapidly usable high-energy
molecules and must therefore locally synthesize ATP to maintain function. We also discovered that synapses
relay on several mechanisms to upregulate ATP that are essential for synapse function. Additionally, we
discovered resting nerve terminals consume large amounts of ATP to maintain the synaptic vesicles proton
gradient but that this energy burden likely varies across neurotransmitter type. We propose to test the
hypothesis that neurodegenerative diseases have a strong local metabolic component by examining how
genetic drivers of neurodegenerative disease specifically impact the local metabolic balance and do to
determine if this might be a driver of disease-driven synapse impairment. Although certain neurodegenerative
diseases disease initially present with other overt symptoms (for example movement disorders) over time they
most frequently convert to dementias in the majority of patients. Here using quantitative approaches we will
determine how nerve terminals in a metabolically vulnerable neuron population rely upon glycolysis versus
oxidative phosphorylation to support function, examine if maintaining the vesicle proton gradient places a large
energetic burden on the nerve terminals (Aim1), determine if the disease mutations associated with
mitochondrial integrity specifically impact the balance of ATP (AIM2) and determine if a number of other known
disease associated mutations increase metabolic vulnerability by altering the local balance of ATP production
versus consumption in this critical neuron population (Aim3). The lessons and insights learned from these
studies should then prove valuable in informing the pathology of a larger class of dementias.

Public health relevance
The brain is very vulnerable to metabolic problems and synapses, the machinery that mediates the conversion of electrical information into chemical information, are very sensitive to metabolic imbalances. Since neurodegenerative diseases results in improper function of synapses, we hypothesize that these disease states have a strong metabolic component arising from an imbalance in fuel availability and fuel use at the level of individual synapses. The fuel here that matters is a molecule called ATP and our work aims to understand how it is produced at synapses, who consumes it and how in diseases that cause dementia (e.g. Alzheimer’s) this changes.